Multidisciplinary Training Program in Lung Disease

The proposed renewal is for a continuation of the present Multidisciplinary Training
Program in Lung Disease (HL-07185), which provides training in basic and clinical
sciences important to the respiratory system. The program draws on the basic and
clinical research skills of the broad group of faculty at UCSF addressing questions
directly relevant to lung biology and disease. The grant is to accommodate a total of
thirteen postdoctoral trainees, including both MD's and PhD's. The main program is an
actual research experience under the close supervision of a Preceptor and a review
committee selected on the basis of the experimental approaches of the trainee. These
approaches include disciplines applicable at the molecular, cellular, tissue, organ, whole
animal, clinical, or population levels. In addition, considerable emphasis is placed on
special educational opportunities that have been created to prepare individuals for a
diverse range of careers in academic medicine. The educational program provides
small group conferences and seminars and coursework in basic sciences, biostatistics,
epidemiological study design, medical economics, and responsible conduct of research.
Training in methods to enhance reproducibility, with an emphasis on rigor in literature
review and study design and analysis, appropriate inclusion of important biological
variables and authentication of key reagents is woven into all aspects of the training
program. Emphasis is placed on personal instruction specifically designed for individual
trainees and there is a formalized career development planning process with multiple
layers of oversight. Considerable emphasis has been placed on multidisciplinary
interaction in research and training, and on developing and implementing academic
careers in areas of scientific need, especially in those previously underemphasized.
Emerging areas of growth in our program include single cell genomics, synthetic biology,
the biology of the microbiome, health disparities and the social determinants of health.
An additional important area of emphasis is the recruitment and retention of
underrepresented minorities and women in the program. The past and future success of
our multidisciplinary program is predicated on a close collaboration among a widely
diverse faculty, including clinical and bench-oriented scientists and translating this
collaboration to a coordinated approach to research training and career development.

Public health relevance
Project Narrative Lung disease is one of the leading causes of death and disability worldwide, but common lung diseases remain poorly understood and current therapies have serious limitations. There is thus a pressing need for high quality basic, translational and clinical research in lung disease. This application proposes support for the UCSF pulmonary training program that for the past 44 years has trained many of the world’s leading scientists in lung biology and medicine.